Administrative Core

The overall goal of the Administrative Core (AC) is to provide scientific and programmatic
leadership that maximizes the value of the CFAR in supporting HIV research at Johns Hopkins
University (JHU) and its institutional and community partners. The AC ensures that the JHU HIV
research community, regardless of career stage or research setting, has access to the CFAR's
many resources. The AC strives to support, in particular, early stage investigators (ESIs),
individuals from underrepresented populations (URPs), especially investigators from
underrepresented populations, researchers new to HIV, and those conducting research in
Baltimore City or another priority jurisdiction for the Ending the HIV Epidemic (EHE) initiative.
The Core provides direct support to the PI, Executive Committee, Leadership Committee,
Scientific Working Groups, the Baltimore HIV Collaboratory, and the Mid-Atlantic CFAR
Consortium. The Core also manages CFAR finances, leverages institutional resources, and
regulatory and fiscal compliance. Additionally, the Administrative Core conducts regular reviews
of CFAR productivity and performs ongoing strategic planning.